TAK1 signaling in Rhabdomyosarcoma tumorigenesis and growth

Abstract
Rhabdomyosarcoma (RMS) is a type of malignant (cancerous) sarcoma that typically arises in
or near muscle beds and shows features of myogenic differentiation, such as expression of
myogenic regulatory factors and muscle structural proteins. However, RMS cells continue to
proliferate and do not undergo terminal differentiation. Transforming growth factor β-activated
kinase 1 (TAK1) is a major signaling protein involved in the activation of various intracellular
pathways. However, the role of TAK1 in RMS or any other sarcoma has not been investigated.
Our preliminary results demonstrate that TAK1 is highly activated in both embryonal RMS and
alveolar RMS cells and human RMS samples. Inhibition of TAK1 using genetic or
pharmacological approaches represses epithelial-mesenchymal transition (EMT) and cancer
stem cell phenotypes in cell culture and in vivo models of RMS. Inhibition of TAK1 also
improves differentiation of various RMS subtypes cell lines into myogenic lineage and inhibits
tumor formation by promoting myogenic differentiation in xenograft. In addition, TAK1 forms a
complex with intracellular myostatin protein in RMS cells. However, the cellular and molecular
mechanisms by which TAK1 promotes tumorigenesis and impairs differentiation of RMS remain
entirely unknown. Furthermore, therapeutic potential of inhibition of TAK1 in RMS has not yet
been examined using preclinical animal models. Based on our preliminary studies, we
hypothesize that aberrant activation of TAK1 causes tumorigenesis and growth of RMS and
inhibition of TAK1 can be a potential therapeutic approach for RMS. In this project, we will
investigate the molecular mechanisms through which TAK1 induces tumorigenesis and inhibits
myogenic differentiation in RMS (Aim I); investigate the signaling mechanisms through which
TAK1 causes CSC enrichment and inhibits differentiation of RMS (Aim II); and examine the
therapeutic potential of inhibition of TAK1 on xenografts and patient-derived xenograft (PDX)
models of RMS (Aim III). Our study aims to identify a novel therapeutic target that plays a critical
role in the induction of tumorigenesis and suppression of myogenic differentiation in RMS. Our
unique strategy to target tumor progenitor cells and differentiation of RMS through modulating
TAK1 will open new avenues to treat RMS.

Public health relevance
Project Narrative Rhabdomyosarcoma (RMS) is a malignant soft tissue sarcoma that has a higher incidence in young age children. Even though RMS patients are treated with multimodal therapy that includes surgery, radiotherapy, and chemotherapy, the survival rate for RMS patients with distant metastasis is only about 20% to 30%. Our project will identify key mechanisms and molecular targets to prevent tumor progression in RMS patients in future therapies.